Using Outcomes to Guide Treatment of Surgical Emergencies

Emergency general surgery (EGS) conditions are defined by a group of acute, non-trauma diagnoses that require
presentation to an emergency department for operative or non-operative care. In the US, 3-4 million adults are
hospitalized and treated for an EGS condition each year such that EGS conditions are responsible for 7% of all
hospitalizations. EGS conditions result in an estimated 800,000 operations annually and cost ≈ $28 billion. The
burden of EGS on inpatient care is greater than that of a new diagnosis of diabetes or cancer, coronary heart
disease, heart failure, stroke, or HIV. Older adults, who are at increased risk of adverse outcomes, comprise
more than half of the adult EGS population. Operative management of EGS conditions results in an overall
complication rate of 50%, with a readmission rate of 4-18%, and a mortality rate that can approach 15%, with
older patients demonstrating a significantly higher risk. Non-operative management is considered a reasonable
alternative yet studies show mixed results. Randomized control trials are limited by the invasive nature of
operative treatment, the heterogeneity of conditions, and the acute nature of EGS. Furthermore, most trials have
compared different types of operative or non-operative interventions, with relatively few comparing operative
treatment to non-operative treatment. A lack of evidence on the comparative effectiveness of operative and non-
operative treatment has been shown to result in unnecessary variations in treatment and inferior operative
outcomes. Furthermore, given the growing interest in the development of a regionalized system of care for EGS
patients since the Institute of Medicine Committee report on the Future of Emergency Care in the United States
Health System, knowledge on hospital performance in EGS is needed. This proposal aims to address these
gaps in the literature with the following specific aims: (1) To identify hospital-level factors associated with rankings
in EGS performance, (2) To evaluate the comparative effectiveness of operative and non-operative treatment in
specific EGS conditions and (3) To evaluate heterogeneity in the effectiveness of operative treatment.
Conditional effects of age, dementia and race will be examined amongst others. Using nationwide data from
Medicare beneficiaries, the proposed study will be the first comparative effectiveness analysis of operative and
non-operative treatment in EGS. The proposal employs: (1) template matching to define hospital quality in EGS
(2) an instrumental variable approach with optimal near-far matching to overcome confounding by indication and,
(3) interaction models to examine the conditional relationship between treatment and outcomes by patient
factors. In so doing, the findings will provide insights into hospital factors necessary for optimal EGS outcomes
and the comparative effectiveness of OP of EGS conditions. Policy makers will have evidence to inform systems-
level restructuring to address the crisis in emergency care. Patients, caregivers and providers will benefit from
the resultant high value care.

Public health relevance
In response to the ongoing crisis in emergency care and the burden of emergency general surgery (EGS) on older adults and their caretakers, we propose a comprehensive study of EGS in the national population of Medicare beneficiaries. We will (1) rank hospitals on EGS quality to define factors associated with best practices, (2) perform a comparative effectiveness study of operative treatment of EGS conditions, and (3) examine the conditional effects of treatment by patient characteristics. This proposal will address critical gaps in knowledge and generate results to advise (1) patients on hospital factors to consider when seeking care for EGS conditions, (2) policy makers on strategies for systems-level restructuring, and (3) surgeons on the optimal treatment of EGS conditions.